New Mexico Center for Metals in Biology and Medicine - Equipment Supplement

Administrative Suppl. for Equipment Purchases for NIGMS-funded Center and Core Facilities NOT-GM-21-029 Summary Inorganic metals have long been a focus of biomedical research in New Mexico, due to the high prevalence of mining-related metal contaminants in the region. At the University of New Mexico Center for Metals in Biology and Medicine (UNM CMBM), our main focus is on both studying adverse health outcomes of metal contaminants as well as on harnessing the chemical properties of metals for therapeutic and nutritional purposes. Detailed knowledge of molecular interactions between metallic species and biomolecules can lead to clinical and population-level interventions to improve public health. Towards this end, we have established a new Integrative Molecular Analysis Core (IMAC) to provide members, and the UNM Health Sciences Center campus, with cutting edge analytical chemistry instrumentation and techniques. is launching, still in its first year, and seeing a surge of user interest and activity. In responding to needs of our research community, several specific analytical applications require additional specialized instrumentation for high-accuracy small molecule quantitation have been discussed. To provide the membership with a workhorse machine that can handle targeted metabolomic and lipidomic assays, as well as examine DNA damage, oxidative biomarkers, and metal-associated biomolecules, the Sciex 5500+ Triple QuadTM offers a superb cost-effective system to meet our diverse quantitation needs. Featuring a high level of sensitivity, selectivity and linear dynamic range, it allows for the most demanding quantitation analyses, such as challenges of severely interfered low-level trace quantification that are commonly encountered during analysis of specific metabolites and biomarkers in biological and environmental samples. Triple Quad LC-MS/MS systems deliver superior quantitative results in a single injection workflow. By offering robust targeted quantitative analysis of known small molecules such as metabolites, biomarkers and peptides of interests, it is a highly beneficial addition and expansion to our Orbitrap LC-HRMS platform that is preferentially used for non-targeted protein analysis. This state-of-the-art system is the first of its kind on our HSC campus. It will complement our current MS systems to provide new and extended applications for our user base. Moreover, faster and more sensitive instrument will help with our constant development of innovative bioanalytical methods to meet new research needs of our users. Establishing this capacity at UNM will certainly meet the needs of a wider audience and expand the value of our IMAC for the UNM HSC. Therefore, the 5500+ system will enhance our user access to and impact of the resource, improve the productivity and efficiency in the laboratory, and help sustain the Core.

Public health relevance
Administrative Suppl. for Equipment Purchases for NIGMS-funded Center and Core Facilities NOT-GM-21-029 Summary Inorganic metals have long been a focus of biomedical research in New Mexico, due to the high prevalence of mining-related metal contaminants in the region. The University of New Mexico Center for Metals in Biology and Medicine has established a new Integrative Molecular Analysis Core to provide members, and the UNM Health Sciences Center campus, with cutting edge analytical chemistry instrumentation and techniques. To provide the membership with a workhorse machine that can handle targeted metabolomic and lipidomic assays, as well as examine DNA damage, oxidative biomarkers, and metal-associated biomolecules, we will install a new Sciex 5500+ Triple QuadTM LC-MS/MS.